Overcoming humoral rejection after xenotransplantation in sensitized nonhuman primate recipients

Abstract
Xenotransplantation has long been proposed as a therapeutic strategy to address the ongoing organ shortage
in transplantation. In recent years, pig-to-primate xenotransplantation outcomes have dramatically improved
following advances in the genetic engineering of pig donors and utilization of costimulation blockade-based
immunosuppression, such that translation to the clinic appears within reach. Highly allosensitized patients,
those who have developed anti-donor antibody as a response to foreign HLA exposure, are potential first
candidates for xenotransplantation given their reduced chances of undergoing allotransplantation. However,
the impact of allosensitization in the setting of xenotransplantation has not yet been fully elucidated in pig-to-
primate models. Our preliminary data suggest that allosensitization promotes antibody-mediated rejection
(AMR) following kidney xenotransplantation and leads to early graft failure. Use of donor kidneys from highly
engineered pigs prolong xenograft survival yet do not fully alleviate AMR development. Additional therapeutic
strategies are thus needed to dampen the post-transplant humoral response following xenotransplantation in
sensitized recipients. This project aims to evaluate novel desensitization and immunosuppression strategies to
control the post-transplant humoral response and foster long-term xenograft survival in sensitized recipients.
Our overarching hypothesis is that both conditioning the host immune response ahead of xenotransplantation
through desensitization and continuous targeting of B cells, plasma cells, or complements following
transplantation, are necessary to control the post-transplant humoral response and alter the repopulating
xenoreactive immune repertoire to favor long-term graft acceptance. To explore this, we propose 3 specific
aims: Specific aim 1: We will define the effects of desensitization (costimulation blockade and proteasome
inhibitor) pre-transplant in rhesus monkeys undergoing kidney xenotransplantation. Specific aim 2: We will
define the impact of adjuvant therapies targeting downstream elements of the humoral response following
xenotransplantation. Specific aim 3: We will identify the functional phenotype of xeno-specific T and B cell
repertoires required to establish long-term AMR-free xenograft survival while preserving anti-viral/vaccinal
response. These advances will ultimately position us to conduct a first-in-human xenokidney transplantation in
sensitized patients testing this optimized immunosuppressive regimen. Our proposal involves many academic
and industry collaborations that are ongoing as attested by letters of support. The impact of this proposal has
broad implications that may benefit U.S. citizens affected by end stage renal failure or by immune-mediated
illnesses or infections.

Public health relevance
PROJECT NARRATIVE Transplantation is a cure for many end-stage organ diseases. Highly sensitized patients, those who have developed anti-donor antibody prior to organ transplantation via pregnancy, transfusion, or previous transplantation, remain challenging to transplant compared to their non-sensitized counterparts. As a result, sensitized patients stay longer on the waitlist and experience higher rates of mortality/morbidity. Xenotransplantation has long been proposed as a therapeutic strategy to address the ongoing organ shortage in transplantation and highly sensitized patients have been suggested to be potential first candidates. Xenotransplantation outcomes have improved over the last years due to progress in gene editing of the donor pig as well as improved immunosuppression. Despite this, antibody-mediated rejection (AMR) remains common and prevents long-term graft survival and clinical translation. Therefore, this project seeks to use a preclinical nonhuman primate model to test new therapeutic strategies targeting post-xenotransplantation humoral response, with the ultimate goals of minimizing graft rejection, preserving protective immunity, and maximizing patient health. The results of the study would directly inform the strategy for the first human xenotransplants and lower the risk of humans undergoing xenotransplantation. We anticipate future advances to move into clinical trials to help further prolong kidney transplant function and patient survival, thus extending the lifespan and quality of life of patients with kidney failure.